NIDA Epidemiology Training Program

Given the growing burden of substance use and rapid shifts in how we study substance use (SU) and
substance use disorders (SUDs), there is a critical need for a well-trained and diverse workforce to conduct
impactful research on SU and the complexity of its consequences. Responding to this need, we propose renewal
of the Drug Dependence Epidemiology Training (DDET) program at Johns Hopkins Bloomberg School of
Health (JHBSPH). DDET has provided research training for >29 years and has produced many of the nation’s
leading SU researchers. We benefit from strong institutional support for training, comprehensive course
offerings in epidemiology and statistics, and research in SU at JHBSPH and across Johns Hopkins University.
Recent accomplishments have been exceptional, indicating that DDET continues to make a tremendous
impact on the field. Among those who completed training in the current project period, all predoctorates
completed their doctoral degrees in 4 years; all trainees (both pre- and postdoctoral) continued in research
careers; and 8 (of 13) postdoctorates are in faculty positions.
The DDET team includes two co-directors (Maher, Johnson), five associate directors (Sherman, Latkin,
Mojtabai, Linton, Thrul), and 33 additional faculty (9 core, 24 affiliate). The participating faculty have sub-
stantial research expertise in substance use and SUDs, and all will work together to implement the training plan
and provide trainees with opportunities to engage in supervised research.
The DDET program has strong and stable leadership, highly-qualified faculty, clear and relevant program
goals, and an ongoing record of excellence. Our mission is to create the next generation of scientists who will
tackle the challenges of substance use, SUDs, and their related harms. Our 5-year goals are to train scholars
who will: [1] investigate the causes and consequences of substance use and SUDs; [2] respond to gaps in
treatment and services for SUDs; and [3] develop, implement, evaluate, and scale-up interventions to address
substance use, SUDs, and their related harms.
DDET is designed to provide broad knowledge in the fundamentals of research in substance use
epidemiology, services, and prevention, as well as specialized training in one or more of the focal areas. With
this competing renewal, we propose to provide cross-disciplinary, specialized research training in drug use for 7
pre- and 7 post-doctoral scholars. We have identified 5 focal areas that will enhance the quality and relevance
of training, each is led by an associate director. Focal areas include: [1] harm reduction & overdose prevention;
[2] interventions for SUD & infectious disease; [3] SUD & psychiatric comorbidities; [4] structural
determinants & drug control; and [5] emerging trends & technologies. Cross-cutting training areas include
polysubstance use, health equity, and human dignity. Training activities include coursework, seminars and
webinars, research apprenticeships, participation in scholarly meetings, and other integrative activities.

Public health relevance
Public Health Relevance In this renewal application we propose the continued development of the Drug Dependence Epidemiology Training (DDET), a program to support pre- and post-doctoral training in substance use and substance use disorders. Our goal is to increase the number and quality of health professionals who apply expertise in epidemiology, biostatistics, prevention science, and services research to substance use research use research. We have a demonstrated commitment to enhancing diversity within the drug research community, as well as special emphasis in training on: HIV and Hepatitis C, epidemiological and statistical methods, social and structural factors, psychiatric disorders, and emerging issues, such as overdose prevention and SARS-CoV-2.